Fibrin(ogen) Structure and Interactions

PROJECT SUMMARY
Fibrinogen is a multifunctional plasma protein that, after conversion into polymeric fibrin, promotes
hemostasis and plays a pivotal role in various physiological and pathological processes, including wound
healing, thrombosis, atherogenesis, tumorigenesis, and more. Inflammation and angiogenesis are integral
parts of wound healing; however, in pathological settings, these two processes contribute to the development
of inflammation-related cardiovascular diseases and the progression of tumor growth and metastasis. Our
previous studies primarily focused on the newly discovered fibrin-VLDL receptor-dependent inflammatory
pathway, which promotes the transendothelial migration of leukocytes and, consequently, inflammation. In
these studies, we established the molecular mechanism underlying this pathway and hypothesized that the
fibrin-derived β15-42 fragment, which was shown to exhibit significant protective effects in numerous
inflammation-related animal models, inhibits this pathway by interacting with a putative receptor. Recently,
we discovered that endothelial N-cadherin is a novel receptor for fibrin. Our extensive preliminary data
suggest that N-cadherin is a putative receptor for β15-42, and the interaction of fibrin with this receptor
promotes angiogenesis. Based on these data and our previous findings, we propose to characterize the
novel fibrin-(N-cadherin) interaction and establish its role in fibrin-dependent inflammation and angiogenesis.
Specifically, we aim to establish the structural basis for the fibrin-(N-cadherin) interaction (Specific Aim 1),
test our hypothesis that N-cadherin is a putative receptor for the β15-42 fragment, whose interaction with this
receptor inhibits leukocyte transmigration (Specific Aim 2), and test our hypothesis that fibrin-(N-cadherin)
interaction triggers fibrin-dependent angiogenesis (Specific Aim 3). Additionally, we intend to design novel,
efficient inhibitors of the fibrin-(N-cadherin) interaction with potent anti-inflammatory and anti-angiogenic
properties. These inhibitors may be developed as potential therapeutics for treating fibrin-dependent
inflammatory disorders and angiogenesis-related tumorigenesis.

Public health relevance
PROJECT NARRATIVE Inflammation and angiogenesis are integral parts of wound healing process, but in pathological conditions, these two processes contribute to the development of cardiovascular diseases and the progression of tumor growth and metastasis. Fibrin(ogen) plays a significant role in these processes. We have recently discovered that endothelial N-cadherin is a novel receptor for fibrin. Our preliminary data suggest that the interaction of fibrin or its fragments with this receptor inhibits leukocyte transmigration, thereby reducing inflammation, and promotes angiogenesis. The primary objectives of the proposed study are: to establish the structural basis for this interaction, to clarify its role in fibrin-dependent inflammation and angiogenesis, and to design efficient anti-inflammatory and anti-angiogenesis agents that can be developed as potent therapeutics for treatment of fibrin-dependent inflammatory disorders and angiogenesis-related tumorigenesis.